Molecular mechanism of metabolic stress in the pancreatic beta cells

Type 2 diabetes (T2D) is one of the most prevalent chronic disorders with a substantial healthcare
burden. The hallmark of T2D is beta cell dysfunction. High glucose and high lipid levels (herein
referred to as overnutrition) are the two most salient environmental risk factors associated with
T2D. However, the specific impacts of these factors on beta cells, as well as the mechanisms
underlying such impacts, remain unclear. Adding to the complexity is the observation that beta
cells exhibit both adaptive and maladaptive responses to overnutrition, contingent on the dosage
and duration of exposure. The goal of this proposed research is to determine the molecular
mechanisms underlying beta cell overnutrition response. Our central hypothesis is that the
transition from glucolipoadaptation to glucolipotoxicity in beta cells is mediated by epigenetic
programs. To gain a deeper understand of overnutrition-induced beta cell state changes, we have
established an in vitro human beta cell metabolic stress model. We have also generated single-
cell transcriptomic maps from primary human pancreatic islets exposed to metabolic stress as
well as pharmacological induced endoplasmic reticulum stress. Combined with targeted drug
screening, we identified histone H3K9 methyltransferases G9a/GLP to be important mediators of
beta cell stress. Building on these findings, we have developed two aims to translate the
laboratory discovery into mechanistic biological knowledge of T2D. In Aim 1, we will perform a
series of -omic assays with dense time course to delineate the molecular landscape and beta cell
dynamic state changes in response to overnutrition challenge. We will connect the T2D variants
identified by genome-wide association studies with nutrition-responsive chromatin and
transcriptomic changes and experimentally establish causality between variants to functions in
beta cells. In Aim 2, we will dissect the molecular pathways linking overnutrition with G9a/GLP,
and beta cell cellular molecular changes. Together, our study has significant and broad impacts
by providing (1) novel biological mechanisms and therapeutic targets of T2D; (2) a molecular
network encompassing epigenetic regulators, nutrition-responsive cis-regulatory elements, and
their genetic targets in human beta cells that enables interpreting of T2D pathogenesis in
signaling-dependent genetic programs.

Public health relevance
Diabetes is the most prevalent chronic disorder that carries substantial public-health burdens. The proposed research aims to determine the molecular mechanisms regulating the metabolic stress response in pancreatic beta cells. Understanding this process will impact diabetes treatment and therapies.